Microglia-targeted glutaminase inhibition forthe treatment of chronic stress-associated depression

PROJECT SUMMARY
Major depressive disorder (MDD) is a debilitating psychiatric disorder with a high lifetime prevalence, imposing
a severe economic burden on society. Despite a number of clinically effective treatments for MDD, many patients
exhibit resistance to current antidepressants. Thus, novel interventions based on pathological mechanisms of
MDD are needed. We recently discovered that glutaminase (GLS1), the enzyme which catalyzes the hydrolysis
of glutamine to glutamate, is highly upregulated in activated microglia in the brain of mice subject to Chronic
Social Defeat Stress (CSDS), a well-established rodent model used to study stress-induced mood disorders,
including depression. We then reported that inhibiting the elevated glutaminase activity with JHU083, a glutamine
analog prodrug, dramatically inhibited the stress-induced microglial glutaminase upregulation, inflammatory
cytokine induction, and normalized the CSDS-induced social avoidance and anhedonia. Although JHU083
showed therapeutic efficacy, its translational potential is hampered by its propensity to cause gastrointestinal
toxicity likely associated with its reactive diazo group and its non-selective inhibition of all glutamine-utilizing
enzymes, not just GLS1. Given the significant clinical potential of this mechanism, we propose to overcome this
limitation by utilizing our recently developed selective GLS1 inhibitor JHU29 and directly targeting microglial
GLS1 by attaching JHU29 to hydroxyl-dendrimer nanoparticles delivery system. Our team discovered that
hydroxyl-terminated poly(amidoamine) (PAMAM) dendrimers (~4-10 nm) selectively target activated microglia in
the injured brain while showing minimal uptake in healthy brains. This is a highly translational approach, as
targeted dendrimer delivery has been demonstrated to be well-tolerated and efficacious in multiple large and
small animal models and was recently shown efficacy in a Ph2 clinical trial (NCT04458298). We have assembled
a highly experienced team with extensive expertise in neuroinflammatory mechanisms and preclinical models of
chronic stress (Zhu), dendrimer nanoparticles (Rangaramanujam), pharmacokinetics (Rais), glutaminase drug
discovery and clinical translation (Slusher). Together we will develop a dendrimer-glutaminase inhibitor
conjugate (Dendrimer-JHU29) for chronic stress-associated psychosocial behavior deficits by implementing the
following three aims: AIM 1- Synthesize and characterize generation-4 (G4) and generation-6 (G6) Dendrimer-
JHU29 conjugates. AIM 2- Assess their oral pharmacokinetics, microglial target engagement, tolerability, and
biodistribution. AIM 3- Using the optimal conjugate and dosing paradigm from Aim 2, evaluate its therapeutic
and tolerability profile in CSDS and vicarious defeat stress (VDS) mice models. Successful execution of these
aims will result in a Dendrimer-JHU29 conjugate ready for Investigational New Drug (IND)-enabling studies to
support future clinical studies to combat chronic stress-associated depression.

Public health relevance
PROJECT NARRATIVE We recently discovered that glutaminase activity is highly upregulated in activated microglia during chronic stress and that inhibiting the elevated microglial activity relieves psychosocial behavior deficits and inflammatory cytokine induction. Although our glutaminase inhibitor JHU083 showed robust therapeutic efficacy in proof-of- concept studies, its lack of selectivity and propensity to cause gastrointestinal toxicity limits its translational application. Given the significant clinical potential of this mechanism, we propose to overcome this limitation by utilizing our recently developed and highly selective glutaminase inhibitor JHU29 and directly targeting it to microglia using a hydroxyl-dendrimer nanoparticle delivery system, and to evaluate the efficacy and safety of the dendrimer-glutaminase inhibitor conjugates in established mice models of chronic stress.